Suppression of distributed sensory representations by self-motion cues in Drosophila

PROJECT SUMMARY/ABSTRACT
To ensure accurate perception of the world, nervous systems must distinguish between sensory inputs caused
by external stimuli and those generated by the body’s own movements. During rapid eye movements, or
saccades, the brain suppresses sensory signals from self-generated motion through a process known as
saccadic suppression. However, little is known about how this suppression affects the feature encoding
capabilities of specific cell types within a visual network and the impact on broader visual processing. This project
aims to elucidate the neural mechanisms of saccadic suppression using the Drosophila melanogaster model,
which offers unparalleled genetic access and a tractable nervous system with a fully mapped connectome. The
research will focus on the Lobula Columnar (LC) cell network, which encodes specific visual features and is
known to exhibit suppression during body saccades. The project has three specific aims: (1) to characterize the
neural inputs contributing to saccadic suppression in LC neurons through electrophysiological recordings and
connectomic analysis, (2) to evaluate how saccadic suppression affects feature encoding across the LC network
using population-level two-photon calcium imaging and advanced analytical techniques, and (3) to develop a
computational model predicting how suppression impacts distinct LC subpopulations and their contributions to
visual perception. This research will provide fundamental insights into how self-generated motion is processed
and suppressed across visual systems. As part of the fellowship, I will receive training in electrophysiology,
calcium imaging, and computational modeling under the mentorship of Drs. Gwyneth Card, Rudy Behnia, and
Larry Abbott at Columbia University’s Zuckerman Institute. This world-class environment will provide me with the
necessary skills and resources to achieve my long-term goal of establishing an independent research program
focused on sensorimotor integration and neural circuit function.

Public health relevance
PROJECT NARRATIVE Understanding how the brain differentiates between self-generated and external sensory inputs is critical for understanding the neural basis of perception. This research will investigate the neural mechanisms of saccadic suppression, a process that stabilizes visual perception during eye movements, using the Drosophila model system. Insights from this work may provide a foundation for understanding autism and other neurological disorders in humans characterized by altered perception, and could inform future interventions to improve perceptual stability in these and other conditions.